TRAINING PROGRAM IN GENETICS GENERAL AND MEDICAL

The principal objective of our program is to train graduate students to function effectively as geneticists, enabling them to apply the rigor of genetic methods to pertinent issues in contemporary biology and medicine. The variety of approaches taken by the training faculty ensures a broad scope of training that encompasses microbial genetics, human and clinical genetics, yeast and plant geneticists, the developmental genetics of dipterans and nematodes, immunogenetics, aging, population genetics, as well as new directions in genomics. The predoctoral trainees supported by this program gain specific expertise from thesis research in one of these subdisciplines while gaining a broader intellectual outlook from formal coursework, first-year research rotations, and journal club. A well-established program of seminars and other forums for exchanges of research findings lends further perspective and provides valuable interaction with postdoctoral fellows, whose research training is also integrated into the program. Access to medical and clinical aspects of genetics derives both from formal coursework and from association with the Division of Medical Genetics in the Department of Medicine. A greater breadth of expertise is afforded the trainees by our affiliation with other units of the University, including the Departments of Botany and Zoology in the College of Arts and Sciences and the Departments of Biochemistry, Pathology, and Pediatrics in the School of Medicine, as well as with the Basic Sciences Division of the Fred Hutchinson Cancer Research Center.